The relationship between HIV exposure, contact networks, and TB in children under 5 years old

PROJECT SUMMARY / ABSTRACT
More than 200,000 children die each year from TB, of whom 80% are <5 years old. HIV is a leading risk factor
for TB disease in both children and adults. Despite longstanding reliance upon household contact tracing to
identify children with TB, recent estimates suggest that only 10-30% of children with TB are infected within their
households. Meanwhile a massive pediatric TB detection gap exists, with only 40% of children <5 years old
with TB disease being diagnosed and reported. Understanding where and from whom children are infected
with TB is vital to closing this gap. Because adult HIV likely affects both the composition and TB burden of
children’s “contact networks”, it is critical to examine the role adult HIV plays in driving TB transmission to
children. It is likewise essential to examine the interaction between adult HIV and child TB in a growing group
that is highly susceptible to early childhood infections: children who are HIV exposed but uninfected. The
proposed project aims to evaluate the interplay between caregiver/adult HIV infection, complex and dynamic
child contact networks, and child TB exposure and incidence. To do so, in Aim 1 I will leverage the Pediatric
TB Contact Studies Consortium individual patient data meta-analysis database to measure the association
between adult index case HIV status and prevalent and incident child TB infection and disease. In Aim 2, I will
use egocentric social network analysis to track the evolution of social networks among children who are HIV
exposed but uninfected and who are enrolled in a prospective birth cohort study in the Western Cape province,
South Africa. Through this aim, I will explore how changes in social network diversity relate to cumulative TB
incidence in the first 2 years of life in this high-risk population. In Aim 3, I will employ ethnographic methods to
generate detailed assessments of “household fluidity”—a qualitative measure of household composition,
relational ties, and residential structure—to identify opportunities for TB exposure that have been historically
overlooked in traditional household contact tracing. These activities will take place within the rich HIV and TB
academic environments at Boston Medical Center/Boston University and Stellenbosch University (South
Africa), and in the high HIV/TB-burden setting of Worcester, South Africa. Melded with a training plan that
balances coursework, workshops, and hands-on experience, these research aims will provide an ideal
framework for me to develop skills in survival analysis using clustered data, social network analysis, and
ethnography. The proposed projects and training will enable me to become an independent investigator
conducting prospective, longitudinal, social-epidemiological studies at the intersection of pediatric TB and HIV.
An experienced mentorship team led by Dr. Karen Jacobson (Boston Medical Center/Boston University) and
Dr. Graeme Hoddinott (Stellenbosch University) will guide this training and support this research. My goal
through the proposed and future studies is to inform strategies to prevent and detect TB in children, who have
most to lose from and are most susceptible to this perennial pandemic.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is a top-ten killer of children worldwide and is viciously synergistic with the global HIV pandemic. The projects proposed here will use unique databases and novel social network and ethnographic approaches to quantify and describe the relationship between HIV, TB, and children’s social environments. The results will inform child TB case detection strategies and policy to close the pediatric TB detection and treatment gaps in high HIV/TB-burden settings.